Role of DYRK1A/MNB in synaptic growth and function

PROJECT SUMMARY
The nervous system fine-tunes synaptic output to ensure reliable communication, partly through kinase-drive
protein phosphorylation. Alterations in phosphorylation dynamics profoundly affect neurotransmitter release,
synaptic vesicle recycling, synaptic growth and plasticity, and are closely associated with neurodevelopmental
and neurodegenerative disorders. The evolutionarily conserved DYRK1A kinase plays a critical role in
neurodevelopment and is implicated in several neurological conditions, including autism, Down syndrome,
intellectual disabilities, and Alzheimer’s disease. Despite its importance, the precise mechanisms by which
DYRK1A regulates synaptic function remain unclear, and its physiological substrates are largely unidentified.
Using Drosophila as a model, our previous work demonstrated that the DYRK1A homolog, minibrain kinase
(MNB), is essential for synaptic transmission, modulating clathrin-mediated and bulk vesicle endocytosis through
the phosphorylation of synaptojanin. To advance our understanding of MNB functions in vivo, we developed an
innovative approach that integrates proximity labeling with phosphoprofiling to identify novel physiological
substrates and pathways regulated by MNB in neurons. Building on these preliminary findings, this proposal
aims to investigate two novel MNB-regulated pathways at the synapse: selective autophagy and neuropeptide
release. Aim 1 will examine the role of MNB/DYRK1A in regulating autophagy at the synapse. We hypothesize
that MNB phosphorylation of a protein required for selective autophagy facilitates the removal of damaged
synaptic components and toxic aggregates. Additionally, we will investigate the role of MNB-dependent
phosphorylation in modulating TDP-43 aggregation in a fly model of frontotemporal dementia and amyotrophic
lateral sclerosis. Aim 2 will determine and validate MNB/DYRK1A's role in regulating neuropeptide release. The
proposed research will provide critical insights into MNB's regulatory roles at the synapse, offering new
perspectives on the molecular mechanisms of synaptic activity and potential therapeutic avenues for
neurodegenerative diseases. Additionally, our innovative kinase substrate identification method can be broadly
applied to other kinases, offering a powerful tool for future studies.

Public health relevance
PROJECT NARRATIVE MNB/DYRK1A is a kinase implicated in Autism, Down syndrome, intellectual disability, microcephaly, Alzheimer’s disease, and various forms of dementia. Understanding the physiological substrates and functional pathways regulated by MNB/DYRK1A will be essential for elucidating its role in both healthy and diseased neurons.